Integrating Spatial Multi-omics and Clinical Covariates to Identify Mechanisms of Disease in ALS-FTD

Amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD) are part of a fatal and untreatable
disease spectrum that is unified by a diverse presentation of TDP-43 aggregation across central nervous system
(CNS) tissue. Up to 50% of patients with motor dysfunction also present with cognitive deficits and 15% have
frank FTD, but the molecular mechanisms underlying diverse clinical and pathological presentations remain
poorly understood. In our recent work, we have shown that the Edinburgh Cognitive and Behavioural ALS Screen
(ECAS) is a good clinical predictor of extra-motor TDP-43 pathology. Specifically, ECAS subdomain scores
correlate with the distribution of TDP-43 inclusions in brain regions corresponding to the affected cognitive
domains. However, the presence of TDP-43 pathology in a region is not predictive of cognitive deficits associated
with that region. We posit that there may be other, more sensitive, neuropathological correlates of cognitive
involvement that remain to be identified, and hypothesize that additional pathological features--including
nucleocytoplasmic protein mislocalization, perturbations in gene expression, and dysfunctional cell-cell
interactions--may correlate more closely with domain-specific cognitive impairment corresponding to a particular
region of the frontal cortex. We will test this hypothesis through a comprehensive multi-omic analysis of post-
mortem tissue that identifies 1) how differences in cell type-specific subpopulations and intercellular interactions
between ALS-FTD cases and controls relate to protein aggregation and mislocalization and 2) how these
differences relate to cognitive impairment in ALS-FTD. We will accomplish these goals using spatially resolved
proteomic (Aim 1) and transcriptomic (Aim 2) measurements to analyze clinico-pathologically stratified
dorsolateral prefrontal cortical tissue samples (specifically, Brodmann areas BA44 and BA46) from cognitively
impaired ALS patients and age/gender matched controls. By using a combination of approaches to
simultaneously map the spatial transcriptome and proteome of all interacting cellular subpopulations in these
regions, our aim is to elucidate the origins and temporal dynamics of inter- and intra-cellular activities that may
reveal novel diagnostic and therapeutic targets. We have previously implemented Spatial Transcriptomics (ST)
on the spinal cord to identify regional differences within subpopulations of various cell types that vary as a
function of disease dynamics. These data will be directly tied to measures of pathology (e.g., pathognomonic
inclusions). To integrate and analyze relationships between data across modalities, we will develop a
computational framework for harmonized analysis of multi-modal, multi-omic measures of disease burden (Aim
2). Finally, we will implement highly multiplexed immuno-imaging to validate our findings in an independent ALS-
FTD cohort (Aim 3). Our integrated analysis across experimental modalities (single cell RNA-seq, spatial
transcriptomics, multiplexed imaging and proteomics) will yield an unprecedented view of disease pathology and
elucidate neurotrophic and neurotoxic functions that are coordinated within and across different cell populations.

Public health relevance
Amyotrophic lateral sclerosis (ALS) and Frontotemporal Dementia (FTD) are part of a devastating neurodegenerative disease spectrum for which there are no biomarkers and only limited treatments, stemming from a poor understanding of its pathogenesis. Here, we propose to integrate novel computational methods with spatially resolved transcriptomic and proteomic analyses of clinically deep-phenotyped post-mortem ALS-FTD brains to determine the specific molecular underpinnings of functional impairment in this disease. By integrating our analysis across different types of data (single cell RNA-seq, spatial transcriptomics, multiplexed imaging and proteomics), our ultimate goal is to unveil how disease-associated pathology is linked to dysfunction in specific cell types in ALS-FTD, which may in turn foster precision medicine-based treatment strategies.